Integrating social and state cues that motivate vocal behavior

PROJECT SUMMARY
Positive social interactions are critical for mental wellness and physical health. Many mental and
neurodevelopmental disorders affect or are affected by the motivation to socially engage. This motivation is
influenced by a myriad of factors that include external environment, particularly social context, as well as internal
factors such as stress, reproductive status, and energetic state. Typically, the influence of these factors on social
motivation are studied in isolation; however, we know that outside of the laboratory these factors interact and
are integrated with one another. This proposal makes use of a novel system, Alston’s singing mouse (Scotinomys
teguina), to investigate the neural circuit integrating social context and one important dimension of internal state:
perceived energy balance. Singing mice are an ideal species in which to investigate these questions, as
manipulations to social environment (e.g. exposure to potential mates or playback of conspecific song) and
hormonal state (e.g. androgens, glucocorticoids, and leptin) can all influence vocal engagement.
Through three aims, I will test the hypothesis that cues of social context and energy balance are
integrated in specific cell types in the paraventricular hypothalamus. In Aim 1, I will work in the lab of Peter
Strick at the University of Pittsburgh, using rabies virus tracing of inputs to laryngeal muscle to identify the brain
circuit underlying singing mouse vocalization. This aim will confirm that energetic-sensing nuclei sit upstream of
the paraventricular hypothalamus in the singing mouse vocal circuit or allow me to refine my hypothesis and
choose a new target nucleus if necessary. Next, I will work in the lab of my sponsor Steven Phelps, at the
University of Texas-Austin to identify neurons integrating social context and perceived energetic state. In Aim 2
I will use the neural activation marker, phospho-S6, to test the hypothesis that paraventricular hypothalamus
neurons increase activity in response to exposure to females, leptin injections, or both. Then, I will use
PhosphoTRAP, a method of sequencing RNA from recently active neurons, to identify transcripts expressed by
neurons of the paraventricular hypothalamus that are activated by female exposure, leptin injection, or both.
Finally, in Aim 3, I will use single-nucleus RNA-sequencing of the paraventricular hypothalamus to identify cell
types in the region and relate these to candidate markers found in Aim 2. This will allow me to determine whether
transcripts enriched in active cells correspond to specific cell types. Together, these aims will identify a circuit
and specific cell types within it that integrate social and internal cues that influence vocal effort, enhancing our
understanding of the complex processes that drive social motivation and laying the groundwork for future studies
of social motivation and mammalian vocalization using this novel species. Through this fellowship I will gain not
only the technical training described above, but also further training in the responsible conduct of research,
teaching, and mentorship that will be invaluable for my future career in a tenure-track faculty position.

Public health relevance
PROJECT NARRATIVE Social engagement can promote mental health and well-being and is influenced by external factors such as social context, as well as internal factors such as stress, wakefulness, reproductive status, and energy balance. To investigate the integration of such cues, I propose a combination of viral tracing, activity-marker labeling, sequencing of recently active neurons, and single-nucleus RNA-sequencing to identify brain regions and cell types that integrate social context with energy balance to influence social communication. By investigating how internal and external cues shape social motivation, this research will offer basic insights into how and why individuals vary in social engagement, a topic with profound consequences for mental health.